Characterizing sleep disruption as a post-injury immune stressor

Project Summary / Abstract See Research Plan.

Public health relevance
Project Narrative / Public Health Relevance Statement No Change.